The BLAAST Trial: Bangladesh Lung Auscultation AI for Antibiotic Stewardship Randomized Controlled Trial

PROJECT SUMMARY:
This is a submission for a National Institutes of Health R01 award called The BLAAST Project, which aims to
conduct a randomized, double-blinded, placebo, non-inferiority trial of pediatric care enhanced by a novel
automated digital stethoscope, compared to standard care, in Bangladesh (Aim 1) with an integrated
implementation assessment (Aim 2) and economic evaluation (Aim 3) over three years among young, low-risk
children with non-severe clinical pneumonia. Antibiotics are a mainstay of the treatment of acute lower
respiratory infections in young children in low- and middle-income countries (LMICs) like Bangladesh even
though most episodes are caused by self-limiting viruses. Innovative child friendly tools that improve the
diagnosis of respiratory illnesses, safely reduce the unnecessary use of antibiotics, and are suitable for
implementation in LMICs are urgently required to safely improve antibiotic stewardship and stem the rising
rates of antibiotic resistance globally.
In this project (Bangladesh Lung Auscultation Artificial Intelligence for Antibiotic Stewardship or BLAAST) we
aim to utilize a novel FDA-approved digital stethoscope with automated lung sound analytics developed and
validated over a period of ten years from evidence across seven LMICs. In Aim 1, we will determine whether
treatment failure frequency among children in rural Bangladesh managed by clinical guidelines enhanced by a
novel automated digital stethoscope is non-inferior to guidelines alone. We hypothesize treatment failure
frequency among `enhanced IMCI' participants will be no worse than standard care by a +/-2% margin, safely
reducing antibiotic use by 50-60%. In Aim 2 we will assess digital auscultation implementation and antibiotic
use during pediatric respiratory care in rural Bangladesh to inform strategies of antibiotic stewardship. Lastly, in
Aim 3 we will evaluate if a diagnostic strategy enhanced by an automated digital stethoscope is a sustainable
alternative to standard care for children in rural Bangladesh. We hypothesize that care augmented by a digital
stethoscope will have additional benefits via reduced antibiotic use that will outweigh digital auscultation costs
resulting in cost-effectiveness compared to current practice.
BLAAST affords a unique opportunity to evaluate the efficacy of clinical guidelines enhanced by an automated
digital stethoscope on child pneumonia outcomes in Bangladesh, if digital auscultation may be instrumental in
the wider antibiotic stewardship strategy, and whether a digital stethoscope diagnostic tool is cost-effective in
the care of children with respiratory illnesses.

Public health relevance
PROJECT NARRATIVE: In Bangladesh and other low- and middle-income countries (LMICs) antibiotics are readily used to treat acute lower respiratory infections even though most are caused by viruses. Novel tools for diagnosing pediatric respiratory diseases that are feasible for application in LMICs are desperately needed to safely improve outcomes while strengthening antibiotic stewardship. The BLAAST Project plans to conduct a randomized, double-blinded, placebo, non-inferiority trial of pediatric care enhanced by a novel automated digital stethoscope, compared to standard care, in Bangladesh (Aim 1) with an integrated implementation assessment (Aim 2) and economic evaluation (Aim 3) over a period of three years among low-risk children with IMCI-defined pneumonia.